Elucidating the critical role of Wee1 in GIST

Project Summary
Management of gastrointestinal stromal tumor (GIST) treatment has been revolutionized by the identification of
activating mutations in KIT and PDGFRA and clinical application of tyrosine kinase inhibitors (TKIs) in advanced
disease. However, resistance to all approved lines of TKIs is a life-threatening clinical obstacle in metastatic
GIST patients, who have polyclonal tumors comprised of a variety of resistance mutations in KIT/PDGFRA.
Development of effective treatment strategies for refractory GIST requires identification of novel targets. Using
kinome profiling and loss-of function assays, we found that GIST are exquisitely dependent on Wee1 activity.
Wee1 has long been known as a critical G2/M cell cycle checkpoint gatekeeper controlling genomic integrity and
regulating proliferation. However, recent studies have implicated Wee1, both directly and indirectly, in other
cellular functions, including restoration of stalled replication forks and chromatin remodeling. Transcriptome
profiling of TKI-sensitive GIST cell lines highlighted a role for oncogenic KIT/PDGFRA in DNA damage response
(DDR) and replication stress. Our in vitro and in vivo studies revealed significant efficacy of adavosertib (Wee1
inhibitor) in combination with avapritinib (KIT/PDGFRA inhibitor) in TKI-sensitive KIT and PDGFRA-mutant GIST
lines and in a patient-derived xenograft (PDX) model. Furthermore, our preliminary data in the TKI-refractory
setting demonstrated therapeutic synergies between Wee1 inhibition and the topoisomerase II inhibitor,
doxorubicin, at low nanomolar concentrations in a panel of TKI-resistant GIST cell lines, suggesting Wee1
inhibition sensitizes refractory GIST to doxorubicin, providing viable targets beyond KIT and PDGFRA. We
hypothesize that oncogenic KIT/PDGFRA activates DDR proteins to inhibit replicative stress and DNA damage
and maintain genomic stability in GIST leading to resistance to DNA damaging agents. Our preliminary findings
provide a strong premise that Wee1 is a critical mediator of this process and that its inhibition has potential in
the treatment of GIST tumors. Studies interrogating mechanisms of Wee1 and KIT/PDGFRA cooperativity in
response to DNA damage and replication stress in GIST are warranted to understand this critical cell-protective
mechanism in GIST, which may represent a novel therapeutic vulnerability. Ultimately, this proposal seeks to
test the hypothesis that Wee1 inhibition will be a valuable addition to current treatments for GIST patients with
TKI-sensitive or -resistant disease. We believe that the studies outlined in this proposal will provide novel insights
into the role of Wee1 in maintaining genomic integrity as well as preclinical data to support clinical trials in GIST.

Public health relevance
Project Narrative Management of gastrointestinal stromal tumor has been transformed by the identification of activating mutations in the receptors KIT and PDGFRA, and the clinical application of imatinib mesylate (IM) and other tyrosine kinase inhibitors (TKIs) in the advanced disease setting. The success of these TKIs for advanced GIST has been tempered by the reality that treatment only increases the median time to tumor progression by two years in most patients. This proposal uses a multi-pronged approach to leverage impressive preliminary data towards the goal of delivering improved treatment of GIST, specifically in both preventing and/or overcoming therapeutic resistance.